Role of local interneurons in early cortical dysfunction in Shank3 KO mice

PROJECT SUMMARY
Epilepsy and epileptiform patterns of neural activity are extremely prevalent in autism spectrum disorders (ASD)
but the specific mechanisms underlying the emergence of cortical hyperactivity in these conditions remain largely
unknown. Several physiological and morphological abnormalities in cortical GABAergic interneurons have been
observed in both autistic individuals and mouse models of autism, suggesting that cortical interneuron
dysfunction might be a critical factor underlying cortical activity imbalances in ASD. We have recently shown that
mice with deletions in Shank3 exhibit cortical hyperactivity during early postnatal development. Loss of Shank3
results in reduced interneuron activity in response to sensory stimulation in adult stages, but whether similar
phenotypes are present early in development, when cortical hyperactivity emerges, remains unknown. We
hypothesize that loss of Shank3 and subsequent reduction of glutamatergic drive in cortical interneurons is a
primary cause of early cortical hyperactivity in Shank3 KO mice. To test this hypothesis we will use whole-cell
electrophysiology and 2-photon microcopy techniques optimized for studies in developing mice, and characterize
the physiological properties of Shank3 KO cortical Parvalbumin (PV) and Somatostatin (SST)-positive
interneurons, the two major populations of inhibitory interneurons. This effort will identify a potential primary
pathophysiological abnormality underlying early cortical hyperactivity in ASD that will guide the development of
new therapeutic strategies that restore optimal network function during critical periods of cortical development.

Public health relevance
PROJECT NARRATIVE Autism spectrum disorders (ASD) are highly debilitating neurodevelopmental disorders characterized by abnormal patterns of brain development and our previous work has shown that mutations in the ASD risk gene SHANK3 in mice cause cortical hyperactivity during early postnatal periods. We propose to determine whether loss of Shank3 disrupts cortical Parvalbumin and Somatostatin positive interneuron connectivity and function during early postnatal development and address whether these changes are mediated by cell-autonomous loss of Shank3. This effort will provide important new insights into the etiology of Shank3 associated disorders necessary for the development of effective therapeutic strategies.